Structural Biological Studies of Thipeptide Biosynthesis and Engineering

Thiazolyl peptides are natural products with a wide range of biological activities,
including anticancer, antiplasmodial, and antibacterial. Although the natural compounds
are not suitable drug because of poor solubility, many synthetic derivatives are currently
in clinical trials. An understanding of the enzymes that convert peptide substrates into
thiazolyl peptides will significantly aid in producing molecules with better drug-like
properties. We seek to carry out biochemical, and structural biological studies on several
of these enzymes to help guide the production of improved versions of these bioactive
compounds.

Public health relevance
Project Narrative This research plan focuses on understanding how potent antibiotics are made from simple peptides. Knowledge gained from this proposal will allow the production of antibiotics with improved functions.